Developing Activatable Fluorescent Flavonoids for Vascular Imaging

Project Summary/Abstract:
For biomedical imaging applications, fluorescent molecular probes play an essential role, as their use
enables selective display of specific cellular structures and blood vessels. The project seeks to acquire a
modern fluorometer that is capable of detecting fluorescence in near infrared (NIR) region. Such an instrument
is necessary for characterization of the new fluorescent compounds. By enhancing our capability to
characterize the fluorescent properties of new compounds, the requested new fluorometer will speed up the
process in developing the new fluorescent compounds for imaging applications, which is the major goal for the
current NIH research project.

Public health relevance
Project Narrative Fluorescent molecular imaging reagents for blood vessel detection have important applications for medical diagnosis. For example, fluorescein is widely used in ophthalmology to check any blood vessel abnormalities during eye exams. The proposed project acquires a modern fluorescence spectrometer, which will be used to aid the development of new imaging reagents for selective detection of blood vessels. Success in the study could lead to novel imaging reagents, which will enable simplified applications and facilitate a wide range of developmental studies by using zebrafish model organism.